Central auditory processing of natural sound category following sensorineural hearing loss

Project Summary
Noise-induced hearing loss (NIHL) affects nearly one in four U.S. adults, making it the leading cause of acquired
hearing loss, contributing to significant communication challenges and reduced quality of life. These challenges
are particularly severe in complex listening conditions, such as when multiple sounds are present or in noisy
backgrounds. These challenges often persist even with hearing aids. Currently, hearing-aid fitting is based on
the audiogram, which measures hearing thresholds in quiet and does not fully address suprathreshold
processing critical for real-world listening. Several neural mechanisms support complex-sound processing along
the auditory pathway; how NIHL degrades these mechanisms is relatively well characterized in the auditory
periphery, but not in the auditory cortex. Since the auditory cortex directly supports perception of complex
sounds, it is critical to characterize how hearing loss affects cortical representations of complex sounds.
A major impediment to understanding cortical processing in normal and impaired hearing has been the immense
response diversity of auditory cortical neurons. We will address this limitation by using recent advances in large-
scale electrophysiology and machine learning. In parallel, we will behaviorally assess categorization of sounds
presented simultaneously, in noisy conditions – a task designed to capture real-world deficits due to NIHL.
[K99 – normal hearing] Aim 1: We will perform large-scale single-unit recordings while presenting a massive
natural sound corpus and use these data to identify the cortical manifold, which represents a low-dimensional
representation of high-dimensional cortical activity. We will test whether manifold computations generalize
across animals. Aim 2: Next, to reveal the neural basis of sound categorization, we will develop categorization
models based on cortical single-unit data and validate these models using behavior. We will test whether neural
models better match behavior than acoustic models not based on biology. [R00– NIHL] Aim 3: Using tools
(cortical manifold and behavior) developed during K99, we will test whether frequency tuning broadens, inhibition
reduces, and manifold degradation in noise correlates with behavioral deficits following NIHL. Aim 4: To directly
test whether manifold-degradations underlie these perceptual deficits, we will design algorithms to restore the
impaired cortical manifold to normal and compare their efficacy with traditional hearing-aid algorithms in
improving neural representations and behavioral performance. These results will characterize, possibly for the
first time, mechanisms by which NIHL impairs categorization of complex natural sound categories.
Over the course of the project, the PI will be trained in cortical neurophysiology and modern machine-learning
techniques, building on his existing expertise in peripheral neurophysiology, computation (modeling, signal
processing), and translational neuroscience (noninvasive assays, hearing loss). This scientific and professional
training will facilitate the PI's transition into an independent investigator position.

Public health relevance
Project Narrative While modern hearing aids offer substantial benefits, individuals with sensorineural hearing loss still struggle to understand complex sounds in noisy environments. Addressing these persistent challenges requires insight into how the auditory cortex processes complex sounds in normal hearing, how hearing loss disrupts this processing, and how these changes impact perception. Leveraging advanced neurophysiological, computational, and behavioral methods, the proposed project will characterize cortical coding degradations and behavioral deficits due to noise-induced hearing loss and develop audio-processing algorithms to mitigate these deficits.